Child Maltreatment: Innovative Methods for Probing Stress Regulatory Systems and Polygenic Moderation in Child Psychopathology

Project Summary/Abstract.
Child maltreatment, a form of violence inflicted on children, is a complex, insidious problem that,
although occurring more frequently in families residing in poverty, cuts across all sectors of society. The
human costs of child maltreatment are a litany of biological and psychological tragedies that may last a lifetime.
The economic costs for American society are astronomical, with billions of dollars spent in psychiatric, social
services, educational, and justice system costs, as well as lessened productivity for a generation of abused
children. Discovering the processes underlying the development of psychopathology and resilience among
maltreated children offers great promise for informing prevention, intervention, and social policy initiatives.
A multiple levels of analysis approach is integral to understanding the diverse ways child maltreatment
compromises health. Herein, we seek to capitalize on a large data set (N=1135) including comprehensive
assessments of maltreated and demographically comparable nonmaltreated children. Outside the scope of the
original NIH grants, additional biological measures (genotypes; DHEA and testosterone) were obtained with
limited foundation support. Incorporating these biological measures and using innovative quantitative methods
will allow us to significantly advance new knowledge of substantial public health significance.
Extant genetic work associated with child maltreatment has largely been in the context of examining
gene x environment interactions (GxE), focusing on single gene polymorphisms. Given the diverse forms of
psychopathology associated with maltreatment, we posit that multiple polygenic risk composites exist that will
interact with maltreatment to affect child outcomes. We intend to use person-centered methods to differentiate
individuals sharing multiple common genetic polymorphisms involved in the stress response system, and to
advance our understanding of complex polygenic x environment interactions in child maltreatment.
We also plan to investigate the effects of child maltreatment experiences on stress responsive
hormonal systems, specifically the Hypothalamic Pituitary Adrenal (HPA) and the Hypothalamic Pituitary
Gonadal (HPG) axes. Whereas the HPA axis had received considerable attention in regard to the impact of
child maltreatment, attention to the role of the HPG axis and the mutual co-regulation between these axes has
been limited. We seek to expand understanding of dysfunction in these regulatory systems through innovative
statistical modeling. The dynamics of these systems will be examined in association with child maltreatment
and different forms of emerging psychopathology.
The findings will augment the knowledge base regarding the sequelae of child maltreatment and the
etiology of trauma-based psychopathology, and the knowledge gained will inform prevention and intervention
initiatives to divert maltreated children from the development of trauma-related psychopathology and contribute
toward reducing the burden of mental illness in traumatized children.

Public health relevance
Project Narrative. Child maltreatment, including neglect and sexual, physical, and emotional abuse, exerts a pernicious toll on the biological and psychological development of children, rendering them at heightened risk for the emergence of mental and physical disorders across the life course. The findings obtained in this investigation of maltreated and nonmaltreated children will enhance understanding of biological (genetic and hormone) pathways to psychopathology and resilience in maltreated children. Importantly, they also will guide translational research through informing preventive and intervention initiatives aimed at diverting maltreated children from psychopathology and reducing the burden of mental illness in these traumatized children.